SOSIP-NP/mRNA combination for novel preventive and therapeutic HIV-1 vaccine regimens

ABSTRACT
The ultimate goal of the proposed studies is to contribute to ending the HIV/AIDS epidemic. It has been
four decades since the start of the HIV/AIDS epidemic and a protective vaccine or functional cure has been
elusive. In 2020, there was an estimated 37.6 million people living with HIV. Despite highly active anti-retroviral
therapies, hundreds of thousands of people still die from AIDS-related diseases and millions of new infections
continue to emerge. Thus, finding a way to end this pandemic remains a global priority.
The overall goal of the Consortium for Innovative HIV/AIDS Vaccine and Cure Research (CIAVCR) is
to develop an effective combined immunotherapeutic regimen for HIV-1 prevention and cure using the non-
human primate (NHP) model that has a direct path to the clinic for use in humans. There are two FOCI
proposed in the CIAVCR: In FOCUS 1, our overall goal is to demonstrate the correlates and mechanisms of
protection for a protective vaccine, and the role of vaccine-induced immune responses in selecting and limiting
the latent reservoir. The benefits of using novel mRNA constructs to deliver immunogens that can elicit both
humoral and cellular responses will be evaluated. In FOCUS 2, our overall goal is to determine the role of
vaccine-induced immune responses to 1) control HIV-1 infection by reducing the size or eliminating HIV-1
reservoirs, and/or 2) delay plasma virus load rebound. The protective vaccines studied in FOCUS 1 will be
tested to define the mechanisms of vaccine-induced B and T cell responses in clearing HIV-1 reservoirs.
Additionally, novel therapies will be combined with the vaccines to augment clearance of HIV-1 reservoirs.
In both FOCUS 1 and 2, analysis of the breakthrough and latent reservoir Env sequences will inform the
design of new vaccine boosts for an improved protective vaccine regimen that can also limit rebound
viruses.
The NHP-SHIV Centralized Research Resource (CRR) will support the NHP studies in FOCUS 1 and
2 to investigate the effectiveness of vaccine-induced polyfunctional responses and novel immunotherapies
in clearing HIV-1 reservoirs. These studies will use innovative barcoded-SHIVs to determine the effect of
vaccine-induced responses on eliminating the viral reservoirs, and to evaluate the quantity and quality of
viruses that are reactivated by latency reversing agents (LRAs) following treatment interruption.
The Management and Operations Support Unit (MOS) will coordinate the scientific and
administrative activities of this CIAVCR Program to ensure that the FOCI and NHP-SHIV CRR function
cohesively.
By the end of this grant, we expect to have designed a combined preventive and therapeutic approach to
effectively protect from infection and eliminate viral reservoirs—a strategy for effectively impacting the HIV/AIDS
pandemic.

Public health relevance
Approximately 40 million people worldwide are living with HIV/AIDS, and a protective vaccine or functional cure has been elusive despite four decades of extensive research. The proposed Duke Consortium for Innovative HIV/AIDS Vaccine and Cure Research (CIAVCR) program will provide new insights into the effects of vaccine-induced polyfunctional protective immune responses on eliminating HIV latent reservoirs. The ultimate goal of these studies is to develop an effective combined immunotherapeutic regimen for HIV-1 prevention and cure using the non-human primate (NHP) model that provides a direct path into the clinic for use in humans.